NIAAA Pay Plan System Enhancements to add functionality - BASE PERIOD TOTAL PERFORMANCE PERIOD: 09/28/22 - 09/27/23 with two (2) twelve month options to extend to 09/27/2025

NIAAA Pay Plan System Enhancements to add functionality